BEST CARE for Recurrent NMIBC: BladdEr-Sparing Therapy and Cystectomy As TREatments

PROJECT SUMMARY/ABSTRACT
Bladder cancer is the 6th most common cancer in the US and the 4th most common cancer in males. Each
year, more than 80,000 people in the US are diagnosed with bladder cancer and over 17,000 will die. The vast
majority (74%) present with non-muscle invasive bladder cancer (NMIBC). NMIBC has the oldest median age
at diagnosis, intensive surveillance requirements, high recurrence and progression rates (up to 80%), and one
of the greatest lifetime treatment costs of all cancers. Treatment options following recurrence of high-grade
NMIBC include either BST (bladder sparing therapies with significant risk of cancer recurrence and/or
progression) or radical cystectomy (a life-altering bladder removal surgery with substantial short-term morbidity
and mortality). However, patients, their caregivers, and clinicians must make this complex treatment decision
based on limited evidence since bladder cancer research remains underfunded relative to other common
cancers, bladder cancer epidemiology cohorts are uncommon, RCTs have proven challenging to conduct, and
risk stratification models are inadequate. Thus, there is a critical need for high-quality research in recurrent
high-grade NMIBC across the full spectrum of outcomes to inform treatment decision-making. A recently
established and unique cohort can be leveraged to address these evidence gaps. Specifically, the PCORI-
funded Comparison of Intravesical Therapy and Surgery as Treatment Options (CISTO) Study is a large
pragmatic multisite study of patients with recurrent high-grade NMIBC patients who have selected BST or
radical cystectomy to manage their cancer. The CISTO cohort is a unique resource in bladder cancer care and
has potential to serve as the foundation for addressing critical questions relevant to optimal patient-centered
management. However, longer-term follow up of the CISTO cohort is required to fully assess the comparative
effectiveness and harms of management options for recurrent high-grade NMIBC. In addition, incorporating
molecular factors associated with bladder cancer progression has the potential to improve clinical staging and
augment risk prediction models. Finally, the financial impact of new BST options is an important consideration
for patients with what is already one of the most expensive types of cancer to treat. Therefore, we propose the
BEST CARE for Recurrent NMIBC study 1) To compare long-term outcomes (clinical and patient-
reported) between patients undergoing BST or radical cystectomy, 2) To determine whether prediction
of progression to muscle-invasive or metastatic bladder cancer is improved by molecular staging, and
3) To evaluate the impact of newly approved BST options on financial toxicity. We aim to fill substantial
knowledge gaps about long-term oncologic and quality of life (QOL) outcomes, specifically addressing the
continued role of radical cystectomy. If radical cystectomy is associated with better long-term clinical
outcomes, less financial hardship, and similar long-term QOL as BST, in the context of additional information
offered through molecular staging, this would be impactful to clinical NMIBC practice.

Public health relevance
PROJECT NARRATIVE This study has the potential to answer important clinical and patient-centered questions regarding the management of recurrent high-grade NMIBC, specifically identifying which patients would benefit most from radical cystectomy versus continued BST. This could reduce the public health burden of NMIBC by guiding treatment decisions and improving patient outcomes.